Fundamental mechanisms of apoptosis and phospholipid asymmetry

Project summary Programmed cell death, phospholipid asymmetry, and paternal mitochondrial elimination are three vitally important, distinct, and interconnected biological processes essential for normal cell functions and animal development. Defects in these processes can cause various pathological conditions and human disease, including neurodegenerative disease, autoimmune disorders, various inherited human mitochondrial disease, and cancer. In this proposed work, we will carry out molecular genetic, reverse genetic, biochemical, cell biological, biophysical, and functional genomic analyses to decipher basic mechanisms of apoptosis, phospholipid asymmetry, and paternal mitochondrial elimination during animal development. For the study of apoptosis, we hope to understand the regulatory mechanisms and signaling pathways that control the release of mitochondrial apoptogenic factors during apoptosis and identify new targets and downstream pathways of the cell death protease that execute highly organized cell disassembly and rapid removal of the dying cells. For the study of phospholipid asymmetry, we plan to identify the molecular components and regulatory machineries that generate, maintain, and alter phospholipid asymmetry, decipher the functions and roles of specific phospholipids to a cell, and reveal the physiological and pathological consequences of altered phospholipid asymmetry to the cell and the animal. For the study of paternal mitochondrial elimination, we will investigate how and why paternal mitochondria are selectively recognized and targeted for elimination, the paternal and maternal factors and machineries required of this uniparental inheritance process, and the physiological significance of paternal mitochondrial elimination to embryo development and organismal fitness. These studies should reveal novel mechanisms, pathways, and genes that control these three fundamental biological processes, and ultimately, provide new targets, ideas, and strategies to facilitate treatment of numerous human diseases caused by abnormalities in these three important processes.

Public health relevance
Project Narrative Apoptosis, lipid asymmetry in biological membranes, and paternal mitochondrial elimination in embryo development are three vitally important, distinct, and interconnected biological processes essential for normal cell functions and organismal development. Defects in these three processes can cause multiple human diseases, such as neurodegenerative disease, autoimmune disorders, inherited human mitochondrial disease, and cancer. This proposal seeks to understand the mechanisms that regulate and execute these three fundamental biological events and identify new genes and pathways important for these three processes, leading to identification of new therapeutic targets or ideas to treat human disease such as Alzheimer's disease, autoimmune disorders, and cancer that are caused by abnormalities in these three important processes.